Computation Core

Abstract - COMPUTATION COMPONENT
The Computation Component of the Gene Expression Database (GXD) project supports GXD by
maintaining and extending its sophisticated informatics infrastructure. GXD is a rich resource of mouse
developmental gene expression data through which researchers can discover expression patterns crucial for
understanding the function of genes and the molecular mechanisms that underlie human development, health,
and disease. The GXD infrastructure maintained by the Computation Component contains relational
databases, data loading and QC software components, an interactive curatorial interface, a modern web
interface, and multiple bulk data dissemination components. We will evolve the system to enable the new
functionality described in the Curation and Technology Development Components. This will include: ensuring
the robustness of GXD’s information infrastructure through regular maintenance; improving performance by
upgrading our indexing technology stack and parallelizing index distribution; upgrading our curation interface to
a modern web-based platform; refining/retraining our relevance classifier to be more sensitive to scRNA-seq
studies; enhancing the representation of mouse anatomy to encompass developmental differentiation; and
extending metadata capture to include expression in specific cell types. In achieving these aims, we will apply
industry best practices such as agile development methods, automatic regression testing, regular maintenance
schedules, and comprehensive quality control measures.